2',3'DIDEOXYINOSINE ORALLY TO ZIDOVUDINE INTOLERANT HIV INFECTED PATIENTS

Randomized, dose ranging efficacy study of oral DDI in HIV infected patients with aids, ARC, and low CD4 counts or asymptomatic with low CD4 counts who are intolerant to ZDV.